"Developing A Comprehensive Toolkit for Chemical Inducible Epigenome Remodeling"

Project Summary/ Abstract
Distinct epigenetic mechanisms, including histone modifications, DNA methylation, chromatin remodeling
and histone variant exchange, collaboratively and dynamically shape local epigenetic landscape and control
gene activities. Alteration of epigenetic pathways and mutations in epigenetic regulators contribute to the
pathogenesis of various human diseases. Several studies suggest that these epigenetic pathways are
orchestrated to regulate activity-gene expression. Current tools to simultaneously manipulate multiple epigenetic
pathways in temporal and locus specific are lacking. Such tools are necessary to precisely dissect the functional
interplays and crosstalk between these distinct epigenetic mechanisms for gene regulation. To address this
limitation, we propose to establish unique chemical inducible methods that integrate dCas9/gRNA-guided
targeting with the orthogonal chemically induced proximity (CIP) technology to simultaneously control different
epigenetic regulations including all major epigenetic pathways. We will focus on the following three aims: (i)
Develop inducible dual editing platforms for diverse histone modifications; (ii) Develop chemical inducible
platforms for chromatin remodeling and nucleosome editing; (iii) Develop chemical inducible editing platforms
for DNA methylation and validate the orthogonal manipulation of multiple mechanisms across distinct epigenetic
pathways. After finishing this work, we expect to establish a unique toolset that can be readily used by
researchers in the field. This platform can be easily adapted and expanded to manipulate new epigenetic factors
not tested in this study. This new epigenome editing/remodeling platform will facilitate the advancement of
epigenetic research and potentially offer new directions in developing new epigenetic-based therapies.

Public health relevance
Narrative Multiple distinct epigenetic pathways collaboratively regulate gene expression and play key roles in various biological processes and human diseases. However, the functional interplays between these epigenetic mechanisms remain elusive due to the lack of tools to dissect their relationships. This proposal is to establish a comprehensive toolset that enables the simultaneous but independent control multiple epigenetic mechanisms at defined genome locations. This new toolkit will allow the interrogation of crosstalk between distinct epigenetic pathways and the consequences on gene activities. We expect the results from this research will advance our understanding of gene regulation and lead to the development of new therapeutic strategies for human diseases.